Autoimmunity in Cardiopulmonary Toxicities from Radiotherapy andImmunotherapy

Summary
Cardiopulmonary toxicities following thoracic radiotherapy and PD-1 blocking immunotherapy have a major
impact on quality of life and survival. Therefore, there is an unmet need to have early diagnostic test and
intervention for fatal toxicities. Our proposal aims to understand immune mechanisms that modulate
potentially life-threatening cardiopulmonary toxicities. We propose to study the toxicities in both mouse models
and patients by analyzing blood samples. To achieve our goals, we have assembled a collaborative team
across three institutions with a group of expert consultants in order to identify biological correlates and
therapeutic targets to ameliorate these autoimmune toxicities. Our prior studies showed excessive mortality in
mice simultaneously exposed to radiotherapy and PD-1 inhibition, which we show is dependent on both the
cytokine IL-17A and the B-cell. Since both Th17/IL-17A and humoral immunity are implicated in autoimmune
diseases, we hypothesize that toxicities result from the unchecked adaptive Th17 response due to PD-1
blockade, combined with autoantibodies against heart and lung tissues generated by the pro-inflammatory B-
lymphocytes. We will employ mouse models and pharmacological inhibitors to dissect the underlying
autoimmune mechanisms and measure key components of Th17 and B-cell response in prospectively
collected blood samples from lung cancer patients undergoing combine radiotherapy and immunotherapy.
Aim 1: To determine whether IL-17A/Th17 responses mediate the toxicities. We hypothesize that both
innate and adaptive immunity contributes to the toxicities through the link of IL-17A. We will generate KO mice
unable to produce IL-17A through either neutrophils or CD4 T cells. We expect that the toxicities are
attenuated when Th17/IL-17A are blunted in these mouse models. To determine whether IL-17A/Th17 can be
used as predictive biomarkers for the toxicities, we will examine dynamic changes of Th17/IL-17A in serum
samples from our patients. Aim 2: To determine the role of humoral response in mediating the
toxicities. We hypothesize that pro-inflammatory Tbet+ B-lymphocytes drive autoantibody production which
results in the toxicities. We will use Tbetflox/flox CD19cre mice as our model, in which mature Tbet+ B cells are
absent. This approach will be complemented by pharmacological depletion of B cells using anti-CD20 or by
neutralizing autoantibodies with IVIg in wild-type mice. We expect that the toxicities are attenuated in these
models. Furthermore, we will test whether pharmacological inhibitors of Th17/IL-17A reduce Tbet+ B cells and
autoantibodies. Finally, the rise of autoantibodies in blood will be captured in mice and patients as a surrogate
for the toxicities. Our study of basic mechanisms in preclinical models, combined with analysis of patient
samples, will lead to novel diagnostics for early detection and improved therapies for severe cardiopulmonary
toxicities.

Public health relevance
Project Narrative In this proposal, we will investigate autoimmune mechanisms of cardiac and lung toxicities from thoracic irradiation in the presence of PD-1 blockade. Outcomes of the proposed studies will help to identify novel biomarkers for early diagnosis of serious and fatal adverse events and novel therapeutic targets for managing the toxicities and improving therapeutic ratio.